Defining end-user preferences among US women to optimize the design of a long-acting injectable hormonal contraceptive

PROJECT ABSTRACT
Injectable hormonal contraception is an important part of the method mix globally, with depot
medroxyprogesterone acetate (DMPA) the most commonly used injectable product. Many women find
injectables more convenient and discreet than taking a daily birth control pill, and some prefer this
method to device-based longer-acting reversible methods (e.g., intrauterine devices; implants).
Although with ideal use DMPA is over 99% effective, several features have limited compliance and
hence effectiveness, including barriers/inconvenience associated with returning to the clinic every three
months, side effects/menstrual pattern changes, and long/unpredictable return to fertility. In fact, one-
year continuation rates can be as low as 40%. Daré Bioscience is developing a long-acting injectable
(LAI) that provides extended release of etonogestrel with precise control over drug release rate,
targeting windows of protection for six months and 12 months, a rapid return of fertility within two
months, a steadier hormone dose than currently available therapies, and anticipated side effects similar
to Nexplanon® (the currently-approved method of delivering etonogestrel). End-user research is critical
for designing an LAI that users will find acceptable, to increase the likelihood of future uptake and
consistent use. This R43 study, conducted in partnership with the Population Council, comprises end-
user research with US women to understand their preferences for LAI duration in light of other attributes
(particularly effect on menstruation, side effects, and return to fertility), acceptability of the LAIs vs.
other contraceptive methods, and heterogeneity in duration preferences and acceptability between
different end-user profiles. We will leverage Amazon’s Mechanical Turk (MTurk) platform to efficiently
survey a national sample of 1,000 women ages 18-44 years, stratified by age group, urban/rural
residence, and ever-use of hormonal contraception. In Aim 1, we will examine women’s LAI duration
preferences, considering other product attributes, by implementing a discrete choice experiment (DCE),
as well as acceptability of the LAIs compared with currently available contraceptive methods. In Aim 2,
we will identify distinct LAI end-user profiles via latent class analyses (LCA), and LAI duration
preferences for each. LCA models will include end users’ overall perceived acceptability of the LAIs,
socio-demographic characteristics, fertility intentions, reproductive history, and contraceptive
history/general preferences. Findings from this study will directly inform which LAI duration(s) to pursue
and identify the characteristics of US women most likely to be interested in using an LAI. If this R43
study is successful, as defined by confirmation of hypotheses that the LAI would fill unmet contraceptive
needs, we will pursue an evaluation of end-user experiences using our selected LAI prototype(s) within
the first in-human Phase I trial of an LAI.

Public health relevance
PROJECT NARRATIVE Injectable hormonal contraception is an important part of the method mix globally, but several features – especially its three-month maximum duration – limit method satisfaction, efficacy, and continuation. This study entails end-user research to inform the design of a long-acting injectable (LAI) contraceptive currently under development, that targets windows of protection for six and 12 months, a rapid return to fertility, and a steadier hormone dose than currently available therapies. In a national (US) survey with 1,000 18-44 year-old women, we will examine women’s preferences regarding LAI duration and acceptability compared with currently available contraceptive methods, as well as the characteristics of women most likely to use the LAI.